Training in Research Undergraduate Experience through the Rutgers Addiction Research Center: The TRUE RARC Scholar Program

PROJECT SUMMARY
We propose to develop an undergraduate research program that promotes the advancement of students from
underrepresented (UR) groups in the field of addiction research: the Training in Research Undergraduate
Experience through the Rutgers Addiction Research Center, the “TRUE RARC” Scholar Program. The lack of
diversity among addiction scientists is associated with real opportunity costs, from hindered scientific
innovation to persistent disparities in outcomes of substance use treatment for diverse populations.
Undergraduate research programs are necessary to remedy underrepresentation, as they build a bridge to
advanced STEM degrees by helping students envision a future career in research, learn foundational research
skills, and build competencies and self-efficacy. Rutgers is an ideal environment in which to build an
undergraduate addiction research training program. As The State University of New Jersey, Rutgers enrolls
>45K undergraduates across three campuses, each of which ranks highly in diversity and social mobility for
low-income students. Further, Rutgers is home to the largest comprehensive addiction research center in the
United States, consisting of >150 researchers representing more than 40 departments and schools, that
closely coordinates with Rutgers Health, which provides substance use services across the state of New
Jersey. The specific aims of our proposal for the TRUE RARC Scholar Program are: (Aim 1) Develop an
innovative three course sequence (Data Science & Addiction Research 1 & 2, followed by a Capstone course)
to teach students about the foundations of addiction research and data science methods, culminating in a
digital badge representing measured competencies. Our course sequence will make use of the Adolescent
Brain Cognitive Development (ABCD) study data, introducing students to a hallmark NIH resource, while
teaching them about interdisciplinary addiction research, including genetics, neuroscience, and social/
environmental influences on substance use outcomes. (Aim 2) Upon completion of their foundational
coursework, engage 10 or more students from underrepresented backgrounds in six-month, mentored
research experiences in RARC faculty labs, culminating in a research presentation at the annual RARC
symposium. (Aim 3) Provide professional development opportunities for career readiness and graduate school
matriculation by collaborating with our robust network of academic, industry, state, and health care partners.
(4) Create a national resource for addiction research education by building a web repository to publicly
disseminate core aspects from our proposed program, and that of other RARC-affiliated and NIDA/NIAAA-
sponsored training programs, including coursework and professional development content. This will expand
the impact of our undergraduate training program beyond the Rutgers campuses. In summary, our program will
build an undergraduate pipeline into a range of graduate programs, and create associated resources for the
field, to significantly remedy underrepresentation among addiction scientists.

Public health relevance
PROJECT NARRATIVE The present lack of diversity among addiction researchers presents a range of opportunity costs, from hindered scientific innovation to persistent disparities in treatment outcomes. The Training in Research Undergraduate Experience through the Rutgers Addiction Research Center (TRUE RARC) Scholar Program serves to upskill and diversify the next generation of addiction scientists at the undergraduate level via interdisciplinary coursework, lab internships, and career readiness activities to promote a more diverse addiction research field.